Diabetes Research Center

The Diabetes Research Center at the University of Washington is part of the national program supported by
NIDDK and acts as the focal point and umbrella for diabetes research in the Greater Seattle area. Its mission is
to enhance research, education and training in diabetes, obesity, and related disorders and to promote an
environment of collaborative research in these conditions by (1) Providing support to affiliate investigators
through its four biomedical research cores; (2) Conducting a pilot and feasibility program that provides grant
support for new investigators in diabetes research and to established investigators in other disciplines; (3)
Sponsoring an interactive enrichment program comprising symposia, named lectures, retreats and workshops
to inform the community of the latest developments in the area; (4) Ensuring the development of young
investigators by providing postdoctoral and graduate student fellowships for salary support and training in its
biomedical research cores; and (5) Developing new research methods and technologies based on the evolving
needs of its investigators. To accomplish this goal, the Center is organized around four biomedical research
cores (Cellular and Molecular Imaging Core, CRISPR, Vector and Transgenic Mouse Core, Metabolic and
Cellular Phenotyping Core, and Proteomics and Bioinformatics Core) and an Administrative Core that also
manages the Pilot and Feasibility (P&F) and Enrichment Programs. Along with the commitment of the
University of Washington and other Seattle institutions of research space and additional financial support, the
Diabetes Research Center is a dynamic and constantly evolving center that supports 116 Seattle-based
affiliate investigators who receive annual funding in excess of $135.9 million in overall direct costs (more than
$116.2 million of which is from NIH and $24.5 million from NIDDK). These investigators are making important
scientific contributions in the areas of (1) Pathophysiology, prevention and treatment of type 2 diabetes; (2)
Central regulation of body weight and glucose metabolism; (3) Complications of diabetes; (4) Etiology,
pathogenesis and treatment of type 1 diabetes; and (5) Clinical trials and large-scale epidemiologic studies.

Public health relevance
PROJECT NARRATIVE – CENTER OVERVIEW The Diabetes Research Center at the University of Washington has a long-standing tradition and record of facilitating scientific investigation aimed at informing on how best to treat and prevent diabetes, obesity, and related disorders. Through its biomedical research cores, Pilot and Feasibility Program as well as its Enrichment Program, it will continue to support over 120 scientists in the Greater Seattle area and beyond who are pursuing basic, translation and clinical investigation in these areas.